A new animal model to elucidate mechanisms of gene regulation and embryonic patterning

Project Summary
Hox genes serve as critical regulators of developmental processes. Disruption of their function during
embryogenesis results in dramatic “homeotic” phenotypes where regions of the body are transformed from one
identity to another. In humans, these disruptions can lead to malformation of the face, ears, limbs, and
genitalia, as well as neural defects and cancer. In many animal genomes, the Hox genes are found in clusters:
in vertebrates, these clusters are compact, while those of invertebrates are more loosely arranged or
fragmented. While still poorly understood, the structure of the Hox cluster is hypothesized to be important in
regulating their deployment. However, this is difficult to study in vertebrates as their genomes encode multiple
Hox clusters that are the result of whole genome duplications. While invertebrates typically have a single
complement of Hox genes, many invertebrate Hox clusters are disrupted, including those found in the classic
invertebrate model systems like flies and nematodes.
To address this deficit, we have developed resources and tools for studying cephalopod molluscs (squid and
octopus), including chromosome-scale genome assemblies, extensive transcriptomics, and tools for gene
manipulation. Through this work, we have found that cephalopods have a single, intact, but massively
expanded Hox cluster. In fact, they encode the largest Hox clusters yet described – the squid Hox cluster is
two orders of magnitude larger than those found in humans. Conservation of the Hox cluster in cephalopods is
particularly striking given that their genomes are otherwise highly rearranged relative to other animals. Notably,
we have found that cephalopod Hox genes exhibit the canonical, collinear nested domains of expression,
suggesting that elements of the ancestral regulatory program are retained in cephalopods despite the dramatic
increase in cluster size. Surprisingly, our preliminary knockout data suggest that loss of a Hox gene results in
the absence, rather than the transformation, of body regions. These results - the first functional analysis of Hox
genes in a mollusc - point to a fundamentally different mode of action than the homeotic transformations
characteristic of overtly segmented animals like flies and humans. Understanding differences between the
massive cephalopod Hox clusters and the more compact arrangement found in vertebrates will provide
fundamental insights concerning the regulation of these body plan transcription factors across diverse animal
species, including humans. This project is therefore poised to provide transformational insights into the biology
of Hox genes, which play key roles in human development and disease, and contribute to our fundamental
knowledge of how pattern is established in embryogenesis.

Public health relevance
Project Narrative Hox genes are important regulators of axial patterning and disruption of their function or regulation in mammals can result in transformations of vertebral identity, as well as limb and genital malformations. Our proposed studies utilize exciting new insights into Hox genes in cephalopods to elucidate the basic rules governing the regulation and function of this developmental gene family. Through its focus on a critical transcription factor family regulating axial identity, our project will contribute to our fundamental knowledge of how embryonic patterning is established and will provide insight into the biology of this transcription factor family that plays key roles in human development and disease.